CATALYST (Community ClimATe heALth equitY reSearch cenTer)

Summary. Historically marginalized U.S. communities have inequitably high risks of experiencing climate-
induced health impacts. The primary care safety net community health centers (CHCs) serving these
populations are uniquely positioned to prepare for and mitigate these impacts, as CHCs are trusted, culturally
competent care providers in their communities and have expertise in reducing health disparities. To intervene
successfully, CHCs need to be equipped with evidence on: (1) how extreme climate events impact health
outcomes in CHC populations (which differ substantially from those in other care settings); and (2) what
interventions CHCs can enact to effectively prepare for and mitigate these impacts. The Community Catalyst
(Community Climate health equity research center) CCHRC will provide this evidence and the proposed
planning process will prepare the CCHRC to do so as follows. Our Administrative Core will assemble a
transdisciplinary team of experts in climate and health, health equity, social risks and related interventions,
intervention development and implementation / dissemination, health policy, community-engaged research,
and primary care in CHCs. The Administrative Core will also create the data infrastructure needed to study
climate-induced health impacts in CHC populations by linking existing, robust, geocoded research-ready
electronic health record data from the OCHIN Practice-based Research Network (>1,700 CHC clinic sites in 36
states) with existing granular data on extreme heat events and air quality created by Harvard’s Confluence
Project. Our Research Program Core will use this dataset in novel analyses to identify how extreme heat and
poor air quality impact hypertension and asthma incidence and exacerbation in CHC patients, and the effect
modifiers of these impacts. Our Community Engagement Core will convene a learning community of
researchers and diverse representatives from CHCs (leaders, staff, patients) and other relevant community-
based organizations (e.g., public health departments, environmental non-profits). In a multidirectional, iterative
process, this CCHRC learning community will identify: (1) interventions that have potential to mitigate patterns
of climate-induced health impacts in CHC populations, and (2) the research needed to generate evidence on
such interventions’ effectiveness. The CCHRC will then be prepared to immediately begin conducting research
that is led by community-researcher partnerships and designed to address community-identified evidence
needs on how CHCs can prepare for and mitigate climate-induced health impacts in their populations.

Public health relevance
Narrative. The Community Catalyst (Community Climate health equity research center) CCHRC, based on a new partnership between the OCHIN Practice-based Research Network and Harvard’s Confluence Project, will generate the evidence that safety net primary care community health centers (CHCs) need to prepare for and mitigate climate-induced health impacts in marginalized, socioeconomically vulnerable CHC communities. The proposed CCHRC planning process will: generate foundational knowledge on how climate events impact hypertension and asthma incidence and exacerbation in CHC patients, and the patient- and community-level factors that worsen these impacts; and create and support transdisciplinary, community-engaged partnerships that will identify what CHC-led interventions communities prioritize to prepare for and mitigate such impacts, and the research that is immediately needed to assess such interventions’ effectiveness and sustained implementation in CHC populations.